Metabolomics Workbench - National Metabolomics Data Repository

PROJECT SUMMARY/ABSTRACT
The Metabolomics Workbench (MW) – National Metabolomics Data Repository (NMDR) is a unique data
resource that serves the biomedical research community. It was started through the NIH Common Fund
Metabolomics Initiative over a decade ago and has developed into a one-of-its-kind metabolomics data
repository and resource. Projects ranging from independent investigator studies involving metabolic
measurements (funded through R21 or R01 mechanisms) to large national initiatives, including several Common
Fund-driven metabolomics studies, find their home in the NMDR. The NMDR contains almost 3000 studies,
some very large, containing more than 1000 human subjects. The metabolomics data generated by the
researchers can be submitted through easy and facile mechanisms that have evolved over the years by the MW.
The MW-NMDR is widely regarded as one of the most FAIR (findable, accessible, interoperable, usable) data
resources of its kind. The sunset associated with the Common Fund Projects has mandated the need for
mechanisms to sustain data, such as the NMDR, and the RFA offers the mechanism for this perpetuation for the
community. This proposal will address two essential aspects needed for the metabolomics resource.
The first and primary objective of the MW-NMDR proposal is the continuation of the repository and resource
along with the evolution of all features currently present in the infrastructure. The MW-NMDR receives
approximately 50 study submissions, some very large, each month and offers mechanisms for easy upload of
the data followed by curation by the MW team. It is subsequently transferred into a relational database along
with the metadata to make the data discoverable. These mechanisms require continuous maintenance and
updating. The MW also houses a metabolite structure database and RefMet, the reference metabolite
classification and annotation system, which facilitates data harmonization. The metabolite database and RefMet
require continuous updating, an essential task for the MW. The outreach and engagement of the biomedical
research community is another need of the MW-NMDR; continuing this effort with additional mechanisms is a
key objective.The second objective of the MW-NMDR proposal is the enhancement of the infrastructure through
multiple mechanisms. First, the dramatic growth in the data warrants easy discovery mechanisms. Towards this,
we will develop a graph database and query system, which will enable researchers to pose complex
queries/filters to discover data and access them. We will develop a Neo4j graph database along with an
interactive graph visualization interface that will facilitate dynamical queries in a cascading manner. This will
obviate the need for a researcher to learn sophisticated computer skills. Second, we will develop a simple and
accessible human subjects’ clinical metadata model to help create specified cohorts and the associated
metabolomics data. Third, we plan to provide data in multiple formats using tools and interfaces. Finally, we will
develop further the cloud aspects of MW-NMDR and provide AI-ML-ready datasets.

Public health relevance
PROJECT NARRATIVE The NIH Common Fund initiated Metabolomics Workbench – National Metabolomics Data Repository is a unique resource that provides houses and provides metabolomics data for the biomedical research community and serves as a one-stop-shop for metabolomics research. Given its unique status and its service as an invaluable resource for biomedical research, there is an imperative need for its continued maintenance and enhancement. This proposal deals with its continued maintenance with additional improvements and enhancements in the form of new query capabilities, additional discoverability through filtering with human subjects’ metadata, and making the data available on the cloud through extant and AI-ready formats.